Stress Plasticity of CRH Neurons

Summary
Dysregulation of the hypothalamic-pituitary-adrenal (HPA) axis and altered circulating glucocorticoid levels are
closely linked to the development of psychiatric illness, and males and females show differential sensitivity to
acute stress and susceptibility to mental health disorders. Corticotropin-releasing hormone (CRH) neurons of
the hypothalamic paraventricular nucleus (PVN) control activation of the HPA axis and direct stress and
associated behaviors. Changes in CRH neuron synaptic circuits result in altered HPA activity and
glucocorticoid secretion, which cause changes in physiological homeostasis and behavioral outputs. Brainstem
noradrenergic circuits control CRH neuron activity and HPA activation in response to interoceptive stress
exposure, such as immune challenge, while limbic circuits activate CRH neurons in response to psychological
stress. Yet, little is known about the sex-dependent input-output organization of CRH neuronal circuits in the
hypothalamus and how they regulate somatic vs. psychological stress activation of the HPA axis and sex-
specific stress behaviors. Our previous studies in male mice revealed novel mechanisms of somatic stress
activation of the HPA axis via noradrenergic stimulation of a CRH neuronal-glial circuit and dendritic retrograde
volume transmission that stimulates local synaptic circuits in the PVN. We also found a stress-induced
glucocorticoid feedback suppression of the somatic stress activation of the HPA axis in male mice via
desensitization of the CRH neurons to norepinephrine (NE) due to rapid glucocorticoid-induced trafficking of 1
adrenoreceptors out of the membrane. This rapid glucocorticoid effect is specific to somatic stress activation of
the HPA axis. Recent preliminary findings indicate that males and females respond differently to NE, but still
little is known about the sex-dependent stress regulation of the CRH neurons and their afferent and efferent
circuit organization. Here, we will use a combination of ex vivo patch clamp recordings and fluorescence
imaging of CRH neurons, activity-dependent tagging and monosynaptic retrograde tracing of CRH neuronal
circuits in vivo, and stress-associated behavioral assessment to test the hypothesis that discrete somatic and
psychological stress circuits activate distinct CRH neuron populations, which in turn project to
different areas of the brain and drive different acute stress behaviors. Specific Aim 1 will expand on
findings from the previous funding period to determine the sex-dependent mechanisms of NE activation of PVN
CRH neurons. Specific Aim 2 will determine whether CRH neuron subpopulations in the PVN are activated by
discrete afferent circuits driven by somatic vs. psychological stressors. And finally, Specific Aim 3 will extend
this CRH neuron circuit analysis to determine the downstream targets of the somatic and psychological stress-
activated subpopulations of CRH neurons and their respective impacts on stress-related behaviors. Together,
these studies will fill a critical gap in our understanding of the circuit organization of hypothalamic CRH neurons
important for stress modality-specific regulation of the HPA axis and stress-associated behaviors.

Public health relevance
Project Narrative Stress plays a major role in the etiology of mental illness via its dysregulatory influence on hormone-sensitive circuits in the brain, and this differs in men and women. The corticotropin releasing hormone (CRH) neurons of the hypothalamus play a central directing role in stress hormone secretion and stress behaviors. The proposed studies will fill an important gap in our understanding of the basic circuit organization of CRH neurons underlying the effects of stress on the brain by determining the sex-dependent 1) cellular and circuit mechanisms of norepinephrine regulation of the CRH neurons, 2) input-output circuit organization of the CRH neurons, and 3) signaling downstream from the hypothalamus that controls stress-related behaviors.